Structural Basis of Substrate Docking in Intramembrane Proteolysis

In regulated intramembrane proteolysis (RIP), an integral membrane protein is cleaved by intramembrane cleaving proteases (iCLiPs) within the transmembrane domain (TM) to liberate biologically active fragments. g- secretase, an aspartyl iCLiP, cleaves within the transmembrane domain of APP (APPTM) to release amyloid-b peptide, which aggregates to form senile plaque in the brain, a pathological hallmark of AD. The long-term goal is to study the g-secretase and APPTM complex and to delineate the atomistic mechanism of g-secretase and APPTM interaction, and the structural mechanism of RIP. Here we will test a novel hypothesis for substrate/enzyme interaction in RIP and we will use APPTM and an archael presenilin homolog (PSH) as a simplified model system for g-secretase. Using solution NMR, mutagenesis and enzyme assays, we will map the binding sites on both the substrate APPTM (aim 1) and the enzyme PSH (aim 2), and finally derive a structural model of substrate docking to the enzyme (aim 3).

Public health relevance
Alzheimer’s disease (AD) is one of the most serious challenges to public health in US. We will study a novel structural hypothesis of how APP transmembrane domain (APPTM) interacts with the enzyme (γ-secretase) that generates amyloid-b peptide, which aggregates to form the senile plaque, a pathological hallmark of AD. The atomic resolution data on the interaction between APPTM and enzyme will provide tremendous insight into molecular mechanism of γ-secretase and AD pathogenesis, and point to new directions in AD drug discovery.